Alteration and Renovation: UCA & UAM

ALTERATION AND RENOVATION PROJECT SUMMARY/ABSTRACT Modern research space is essential to attract established investigators and to develop the investigative skills of talented investigators and promising students. To strengthen the research capacity of the Arkansas INBRE network, two alteration and renovation projects at partner/affiliate institutions are planned: one at the University of Arkansas, Monticello (UAM) and one at the University of Central Arkansas (UCA). The UAM project will include renovation of approximately 1,000 ft2 of old laboratory space into redesigned research space that is suitable for modern biomedical research. In addition, approximately 770 ft2 of shell space will be finished into a research laboratory, separate microscopy room, a conference/data analysis room. Completion of these projects will provide additional biomedical research space for UAM faculty and students and qualify the UAM vertebrate collection to be listed with the American Society of Mammalogists, which will open new research opportunities. The UCA project will remodel approximately 850 ft2 of outdated research space into a modern biophysics research laboratory. The laboratory design includes configurable benches that will provide maximum flexibility for current and future research projects. The remodeled biophysics laboratory will provide research space for two faculty in the Department of Physics and Astronomy and will supplement a new instructional biophysics laboratory that is planned as part of the expansion of the new UCA Science Center.

Public health relevance
ALTERATION AND RENOVATION PROJECT NARRATIVE The proposed alteration and renovation projects will result in approximately 2,600 ft2 of modern research space that will be used to support biomedical research conducted at two partner/affiliate institutions in the Arkansas INBRE network. Improvement of research facilities within the Arkansas INBRE network will broaden participation of undergraduate faculty and students in research that improves human health.